Clinical and Economic Impact of Teleneurology vs Standard in Clinic Care for Multiple Sclerosis: A Randomized Trial

PROJECT SUMMARY/ ABSTRACT
Multiple sclerosis (MS) patients have higher healthcare utilization, reduced work productivity, reduced quality-
adjusted life years, and lower health-related quality of life (QOL) relative to the general population. The current
standard of outpatient MS care depends on in-clinic visits, but MS patients face many barriers to accessing this
care. These barriers include those resulting from the disease itself, such as physical limitations, driving
restrictions and financial limitations, and they are further compounded by an overall shortage of neurologists.
Furthermore, MS care has a significant economic impact, with the estimated indirect and direct costs for treating
MS in the US estimated to be > $48 billion. Therefore, there is a need to improve access to and reduce cost of
MS care, and telehealth is a potential solution. Both our two multidisciplinary MS Centers (UCSF and Cleveland
Clinic) have demonstrated that telehealth for MS care is feasible and that it results in travel savings for patients,
reduction in missed work, and reduction in caregiver burden. Additionally, patient and provider satisfaction is
high for this modality of care at the time of care delivery. These initial results are promising, but to date there are
no studies assessing the longer-term impact of care delivery via telehealth on the Quadruple Aims of Healthcare:
clinical care, cost, patient experience and clinician experience.
The proposed study will directly bridge these research gaps in the longer-term impact of care delivery via
telehealth. We will complete a two-Center trial, randomizing newly diagnosed MS patients to receive their routine
MS care via telehealth or standard in-office care over 2 years. We will enroll 120 patients (assuming ~ 20%
dropout rate for 100 completers), and will assess and compare standard clinical outcomes, patient-reported
outcomes, costs, patient experience, and clinician care team experience associated with telehealth vs standard
in clinic care. We will also conduct exit interviews with purposefully sampled trial participants to better identify
facilitators and barriers to telehealth implementation. This study will generate needed evidence regarding the
impact of telehealth on clinical outcomes, its cost, and stakeholder experience, and will inform clinical care
implementation in other populations of MS patients and other chronic conditions.

Public health relevance
Project Narrative Our two Multiple Sclerosis (MS) Centers have been at the forefront of deploying telehealth to improve access to outpatient MS care, and, while we have demonstrated both feasibility and high satisfaction at the time of service, there are broader knowledge gaps regarding its impact on clinical outcomes and on the high costs (>$48 billion) of and access barriers to MS care. We propose a 2-year 2-Center randomized pilot trial to determine whether telehealth for MS care in newly diagnosed patients can maintain clinical outcomes, improve satisfaction, and reduce costs of care relative to in-clinic visits. We will also perform detailed qualitative analyses to understand patient and care team experiences, preferences, concerns, and satisfaction regarding telehealth care to identify facilitators and barriers to widespread implementation of telehealth.